Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
HOPE and CAIRHE 2gether (HC2) is built upon the shared goal of improving cancer prevention services and
outcomes in areas characterized by persistent poverty (PP) via “Reach through Equitable Implementation.”
HC2 is a partnership between the Center for Health Outcomes and Population Equity (HOPE) at Huntsman
Cancer Institute (HCI) and University of Utah (U of U), and the Center for American Indian and Rural Health
Equity (CAIRHE) at Montana State University (MSU). The HC2 Administrative Core (Admin) is a critical
interface among Projects, Cores, and community partners, and between HC2 and the Persistent Poverty
Initiative Network (PPIN). HC2’s Admin combines the strengths of two unique centers, HOPE and CAIRHE, to
provide leadership, oversight, and evaluation of HC2 as a whole, its Cores, its Projects, and its early career
investigator development programs—all in the fulfillment of HC2’s mission to improve cancer prevention and
outcomes in areas of PP, especially among populations most impacted in the Mountain West (i.e., American
Indian, Latino, rural/frontier). HC2 will become a regional and national leader in health equity research in PP
areas, building on our already robust foundation of community partners to expand and maintain a broad
collection of healthcare, public health, tribal organizations, and other health equity stakeholders through its
Health Equity Network to Address Cancer Prevention in Areas of Persistent Poverty (HC2 Network). HC2
would be the only multidisciplinary center of its kind in the Mountain West and the HC2 Network would be a
unique regional resource. Under the leadership of HC2 Multiple Principal Investigators (MPIs) David Wetter,
PhD (Contact PI), and Alexandra Adams, MD, PhD, Admin will oversee the progress of the Center’s two
Research Projects (Leaders Schlechter, Estabrooks, Wetter, Tomayko, Adams) and Pilot Projects, along with
the Cores. Admin will establish and convene a robust Community and Scientific Advisory Board (CSAB) and
ensure regular review of all HC2 Projects and Cores by the HC2 Executive Committee and CSAB to ensure
HC2’s success. Admin will also conduct community engagement and outreach activities, fostering collaborative
partnerships with communities (HC2 Network) in support of the Projects and Cores. Strong leadership,
management, and evaluation from Admin will result in more effective Projects and Cores. Moreover, HC2’s
Projects and Cores will refine and improve the way health equity research for cancer prevention is practiced in
tribal and PP communities regionally and nationally. Through these leadership and organizational efforts,
Admin will empower transdisciplinary teams, provide support to early-career investigators, and foster the HC2
Network to enable robust, culturally sensitive community-engaged research addressing cancer prevention and
control among populations living in persistent poverty areas. We will leverage existing infrastructure at HCI, U
of U, and MSU to maximize the impact of HC2’s Research Projects and community-engagement work.

Public health relevance
Through these leadership and organizational efforts and in collaboration with HC2’s respective academic institutions and community partners, the Administrative Core will enable teams to effectively and sensitively conduct community-engaged research addressing cancer prevention and control in persistent poverty communities, as well as provide support to early-career investigators. The HC2 Administrative Core will leverage existing infrastructure at HCI, U of U, and MSU to maximize the impact of HC2’s research projects, community-engagement work, and training of the next generation of health scientists addressing cancer prevention and control in persistent poverty communities.